ACTG 219--PEDIATRIC LATE OUTCOME PROTOCOL

Prospective, longitudinal data collection for late outcomes and late treatment effects of antiretroviral therapy in uninfected infants. The purpose of this study is to follow children who are currently enrolled in or were previously enrolled in pediatric ACTG treatment or drug research studies to look for any late consequences of therapy in growth, neurologic and neuropsychologic function long-term survival and quality of life. Children will be followed until their 21st birthday.